Investigating the impact of a fatty acid-cRel inflammatory circuit in atherosclerosis

R01: Investigating the impact of a fatty acid–cRel inflammatory circuit in atherosclerosis
ABSTRACT/SUMMARY
The objective of this grant to is to understand how inflammation and lipid metabolism are linked via circuits within
macrophages, and whether these circuits influence cardiometabolic disease. Although perturbations in lipid
homeostasis are recognized to be associated with inflammation in a number of human diseases, our
understanding of “how” and “why” the processes are intimately linked remains limited. Recent work has revealed
that pro-inflammatory signals can reprogram the lipid metabolic state of macrophages. It has also become clear
that perturbations in lipid homeostasis can be sensed by the inflammatory machinery of macrophages so as to
induce and to regulate inflammatory responses. Thus, lipid homeostasis and inflammation are interconnected,
and perturbations in one affect the other. In this proposal, we combine advanced analytical mass spectrometry–
based approaches with genetic models of inflammation, with the goal of defining mechanisms by which
inflammation drives reprogramming of the lipidome (and vice versa). Specific Aim 1 is to determine the
mechanisms by which alterations in monounsaturated fatty acid (MUFA) homeostasis regulate inflammation in
activated macrophages. Specifically, we will pursue our discovery that blocking de novo MUFA synthesis
potentiates inflammatory responses via the NF-κB member cRel. Using a combination of transcriptomics, ATAC-
Seq, and ChIP-Seq approaches, we will test the hypothesis that MUFA synthesis regulates inflammatory function
by specifically controlling cRel and the reprogramming the epigenome. Specific Aim 2 is focused on advancing
our understanding of how reprogramming of lipid metabolism occurs in macrophages, and determining the extent
to which reprogramming of lipid metabolism in monocytes and macrophages in vivo. By applying advanced
analytic techniques on tissue resident macrophages under normal, inflammatory and dyslipidemic conditions,
we will determine whether activation signals and lipid environmental cues can induce or shape lipid metabolic
reprogramming in vivo. We also further our understanding of how anti-inflammatory signals or ER stress signals
are integrated into this process of metabolic reprogramming. Specific Aim 3 is to determine the impact of the
SCD enzymes on dyslipidemia, chronic inflammation, and atherosclerosis in mice. The SCD proteins have been
reported to both potentiate and attenuate atherogenesis. We suspect this is due to the complicating factor that
there are multiple SCDs. In this aim, we ask if the combined loss of SCD1 and SCD2 specifically in macrophages
exacerbate inflammation, dyslipidemia and atherogenesis. Conversely, can enforced SCD expression in
monocytes and macrophages protect from disease. Likewise, does loss of cRel ameliorate inflammation and
atheroma formation in response to western diet. It is our expectation that our proposed studies will define, at a
molecular level, why dysregulation of macrophage lipid homeostasis drives inflammation, and how inflammation
influences macrophage cholesterol metabolism in cardiovascular disease.

Public health relevance
R01: Investigating the impact of a fatty acid–cRel inflammatory circuit in atherosclerosis RELEVANCE TO PUBLIC HEALTH Perturbed lipid homeostasis is associated with pathogenic inflammation in a number of metabolic diseases, including atherosclerosis, obesity, and diabetes. In this study, we will elucidate the mechanisms underlying the link between altered lipid metabolism and aberrant inflammatory responses. Our findings may lead to the identification of therapeutic targets in cardiovascular diseases and other metabolic disorders.